Computational and Experimental Resources for Virome Analysis in Inflammatory Bowel Disease (CERVAID)

SUMMARY
While the role of the bacterial microbiome in human health and disease is well established, few studies
have evaluated the contribution of the virome. Recently, we demonstrated that alterations in the enteric virome
in adulthood are associated with diseases such as inflammatory bowel disease (IBD) and AIDS. In a cross-
sectional comparison of IBD cases and household controls, a significant expansion of the Caudovirales, an
order of phages, and anelloviruses, a family of eukaryotic DNA viruses, was observed. Advancing
understanding of the IBD virome beyond this finding is limited by: (1) A lack of well defined longitudinal human
cohorts to enable discovery of temporal associations of the virome with health and disease; (2) The challenge
of viral “dark matter”. Dark matter refers to the typically >50% of the sequences present in purified virus
preparations cannot be classified due to a lack of statistically significant alignment to known reference
sequences. Thus, current virome studies effectively assess < 50% of the virome, thereby compromising our
ability to detect important associations between the virome and disease; (3) Inadequate experimental systems
to manipulate the virome. Although sequencing has identified many novel eukaryotic viruses, there are only
cell culture systems for a limited number of viruses; moreover, there are no small animal infection models for
newly described viruses. In addition while a tremendous diversity of phage has been identified, only a tiny
fraction have known hosts and an even smaller fraction has been cultured. Thus, there are significant barriers
that must be overcome to be able to experimentally test the impact of either eukaryotic viruses or phages in
murine IBD models. These barriers to understanding the role of the IBD virome will be addressed as follows:
Aim 1 will define the enteric virome and bacterial microbiome in a longitudinal cohort of IBD patients and
household controls and identify virome associations with IBD. In Aim 2 novel computational tools to identify
and characterize viruses present in enteric viromes will be developed, including approaches to classify dark
matter. In Aim 3 novel experimental systems for functional virome analysis, including novel cultures of both
eukaryotic viruses and phages as well as animal infection models, will be developed with the end goal of
evaluating causal roles for the viruses and phage in existing muring IBD models. Together, these Aims will not
only address significant barriers in understanding of IBD, but will provide a wealth of tangible computational
and experimental resources to advance the general field of virome studies.

Public health relevance
NARRATIVE The overall goal of this project is to develop novel computational and experimental tools to address challenges in understanding the role of viruses in inflammatory bowel disease. These tools will facilitate studies of not only inflammatory bowel disease, but also broader studies of the relationship of the human virome to other diseases.